Novel Piezoelectric Amino-acid Ultrasound Transducer to Deliver Drugs Through the Blood Brain Barrier

Abstract
Neurodegenerative diseases and brain cancers are challenging to treat due to the presence of blood brain barrier
(BBB), which is formed by tight junctions between endothelial cells in the microvasculature of the brain and
prevents most of the therapeutics from access to the brain tissues. Among several reported approaches,
ultrasound (US) has been demonstrated to be the most effective and safe method to facilitate the BBB opening.
External US is however limited in efficacy to small animals whose skull bone is thin. In the case of humans, the
thick skull bone absorbs more than 90% of US energy, requiring large and bulky arrays of external US
transducers, which often consumes several hours of stimulation and requires tedious MRI monitoring during the
sonication. Moreover, this extensive process is only useful for a single-time stimulation while research has shown
the opening of BBB requires repetitive application of US. Implanted US transducers have thus emerged as an
excellent alternative. Unfortunately, commercial US transducers rely on conventional piezoelectric materials,
which contain toxic elements such as Lead in PZT (Lead Zirconate Titanate) and are non-degradable, therefore
requiring invasive brain-surgery for removal. To overcome these problems, the PI’s group has recently developed
a new biodegradable piezoelectric transducer, based on Poly-L-Lactide (PLLA). PLLA however has a modest
piezoelectric constant and thus cannot generate a powerful US to open the BBB deep inside the brain tissue.
Glycine, a biodegradable and safe amino acid, has been found to possess an extremely high piezoelectric
constant, even comparable to that of piezoelectric ceramics like PZT. Unfortunately, glycine crystals are brittle
and difficult-to-handle, rendering the material challenging to be used for high performance piezoelectric US
transducer. Here, we propose a new strategy for material processing and device fabrication to (1) manufacture
a biodegradable, flexible, easy-to-use, and highly piezoelectric nanofiber film of glycine crystals embedded inside
a polycaprolactone (PCL) polymeric matrix and (2) employ this flexible glycine/polymer nanofibers to create a
powerful US transducer which is implanted into the brain to facilitate drug-delivery through the blood-brain barrier
(BBB) for the treatment of brain cancers. Our major hypothesis is that; the glycine-based ultrasound transducer
will be able to provide a sufficient acoustic wave which can facilitate a safe and transient opening of BBB for the
diffusion of anti-cancer drugs through the BBB to treat brain cancers. To demonstrate the hypothesis, we design
the project with three specific aims. Aim 1 is to assess the piezoelectric performance, characterize the functional
lifetimes, and evaluate acoustic field from the glycine/PCL transducer in vitro. Aim 2 is to asses safety (local and
systemic toxicity) of the implanted transducer and the applied US in a large animal model. Aim 3 is to assess
anti-tumor efficacy of the treatment using the implanted transducer + anti-cancer drugs in vivo.

Public health relevance
Narrative Neurodegenerative diseases and brain cancers are difficult to treat due to the presence of blood brain barrier (BBB), which prevents most of therapeutic drugs from penetrating the tight junctions of endothelial cells in the brain microvasculature and accessing the brain tissues. Ultrasound (US) has been shown to be the most effective and safe method to induce the BBB opening, facilitating the drug delivery into the brain tissue. Here, we propose a novel biodegradable US transducer based on biodegradable, flexible and highly piezoelectric nanofiber film of glycine crystals embedded inside a polycaprolactone (PCL) polymeric matrix to facilitate drug delivery through the BBB for the treatment of brain cancers